Automated Characterization of Arterial Calcification in Dental Cone Beam Computed Tomography as Predictors of Cardiovascular Disease

SUMMARY: The utilization of cone beam computed tomography (CBCT) in dentistry has seen a significant rise,
driven by its superior imaging capabilities that offer detailed 3D views of dental structures and adjacent anatomy.
This allows for more precise interventions in orthodontics, implantology, and endodontics. However, an important
aspect of CBCT's expanding role is the identification of incidental findings, particularly vascular calcifications,
which can be indicative of systemic conditions such as cardiovascular disease (CVD). Detecting these
calcifications early is crucial because they are associated with an increased risk of cardiovascular events like
heart attacks and strokes. While many dentists utilize CBCT in their daily practice, this finding may go unnoticed
due to lack of experience and familiarity with the complex craniofacial anatomy. Furthermore, currently, there
are no established quantifiable metrics for prediction of CVD based on the imaging appearance, severity, and
extent of vascular calcifications from CBCT. By recognizing these incidental findings, dental professionals can
play a pivotal role in the early referral of patients to medical care, potentially mitigating the risks of severe
cardiovascular outcomes and enhancing overall patient health.
The proposed research involves the development of an automated tool to detect and characterize arterial
calcifications in dental CBCT. A major challenge in dental image segmentation is the limited availability of high
quality and large volume of training datasets. Additionally, the segmentation target (the arterial calcification
region) is extremely small (< 1% of the entire image volume), rendering existing approaches suboptimal. Unlike
traditional deep learning segmentation techniques that rely on vast amounts of training data, and where the
segmentation target is not small, this work proposes to develop a framework that leverages an anatomy-driven
self-pretraining paradigm to segment the calcifications reliably and robustly even when training data is limited
and the target region substantially small. Though vascular calcifications have been shown to be associated with
risk of CVD, the imaging presentation of these calcified regions in CBCT is relatively understudied. Having a
quantifiable metric for prediction of CVD based on the severity and extent of vascular calcifications from CBCT
data can assist the clinician with an objective risk assessment. This work is based on the hypothesis that
morphometric and textural features from these regions have significant predictive value; this will be studied using
novel radiomic analysis. Leveraging cutting edge computational approaches, this project will be the first to study
CBCT extracted subtle “sub-visual” computational imaging features in addition to traditionally investigated clinical
risk factors to strengthen the risk prediction models’ predictive capabilities. Successful completion of the project
will result in establishing specific measurable imaging features that provide risk stratification better than
conventional clinical metrics. The team will develop these computational imaging and machine learning tools
using a set of N=1000 CBCT scans obtained from Stony Brook School of Dental Medicine.

Public health relevance
PROJECT RELEVANCE: Cone beam computed tomography (CBCT) is evolving into the standard of care for diagnostic imaging in many facets of dentistry, however, there is growing concern about potentially significant incidental findings going unnoticed by dentists due to lack of experience and familiarity with the complex craniofacial anatomy. Arterial calcifications are among these incidental findings with proven association with CVD. Currently, there are no established quantifiable metrics for prediction of CVD based on the imaging appearance, severity, and extent of these calcifications. The goal of this project is to automatically detect these calcifications, quantify their imaging appearance, and explore their implication in CVD prediction using computational image analysis, radiomics, and self-supervised learning techniques.